Human-centered design of clinical AI to support the diagnosis of pediatric suprasellar tumors

PROJECT SUMMARY/ABSTRACT
Clinical decision-making in subspecialties, like pediatric neuro-oncology, is becoming increasingly data-
driven and complex. Artificial intelligence (AI) is a powerful tool that can help distill this expanding dataset to
present the clinician with the right information at the right time. AI has had little success in clinical applications
so far, but new methods (like OpenAI's DALL-E or GPT3 models) are now in the public eye, clearly demonstrating
the power of the technology generally. Effective translation of that technology into the clinical setting requires a
comprehensive understanding of the specific clinical setting, such as personnel/roles, data/technology used,
clinical goals and workflows. Human-Centered Design (HCD) is a solution framework that emphasizes the needs
of the people who perform a specific task and is well suited to facilitate the design of clinical AI. However, HCD
is challenging to execute in this space because it is difficult and expensive to assemble a team of experts that
spans clinical medicine, artificial intelligence, visualization, and social sciences. Academia and industry have
established multidisciplinary HCD/AI teams but are seeking solutions for filling interdisciplinary leadership roles
in these teams.
I previously published a deep learning model for classifying pediatric suprasellar tumors from
preoperative MRI. My model performed as well as human experts on the same dataset (86%), which was also
congruent with previous studies on human expert performance on the task. In addition, pediatric suprasellar
tumors are almost always diagnosed via surgical pathology, with roughly 8% of patients being radiographically
diagnosed. Preliminary data (Aim 2) suggests that we can improve the deep learning model performance up to
95% by incorporating a Bayesian methodology to estimate model uncertainty. Additional preliminary data (Aim
3) indicates that embedding my model into Google's What-If Tool (WIT) can help clinicians radiographically
diagnose these tumors with less perceived difficulty and greater perceived confidence. Therefore, this proposal's
central hypothesis is that explainable AI solutions can improve human experts' pediatric suprasellar tumor
radiographic diagnosis beyond the current performance levels. Moreover, using an HCD approach, Google's
What-If Tool (WIT) can be adapted into the clinician's workflow in a manner that will result in adoption of this
assistive technology. I will investigate my aims, specifically designed to provide functional knowledge in these
topics to enable me to effectively lead a multidisciplinary team of subject-matter experts in developing robust
clinical AI tools. I am guided by an expert team of mentors representing pediatric neuro-oncology, neurosurgery,
AI, visualization, and HCD. Completion of this proposal will significantly contribute to my career goal: to be a
leader in the application of HCD to develop clinical AI technology that supports pediatric neuro-oncology patient
care.

Public health relevance
PROJECT NARRATIVE Human-centered design (HCD) is a paradigm for problem-solving that is gaining attention in the development of explainable artificial intelligence for clinical decision support, but implementation is hindered because it requires a multidisciplinary team of sociotechnical and clinical experts. Building on my unique background of over 10 years in clinical pediatric neuro-oncology and my previously published work and preliminary data in developing clinical artificial intelligence (AI), my proposal applies HCD methods to make usable clinical AI to improve clinical experts' ability to non-invasively diagnose pediatric suprasellar tumors. Upon completing this work, I will have the necessary multidisciplinary skill set to become an independent scientist focused on applying HCD to develop AI in pediatric neuro-oncology.